Accelerated aging after chimeric antigen receptor T-cell therapy (CART): Leveraging a novel population of cancer survivors to elucidate mechanisms of dementia

PROJECT SUMMARY/ABSTRACT
Aggregations of misfolded proteins (e.g., tau, amyloid-b) are known to play a causal role in Alzheimer’s disease
(AD) and related dementias (i.e., frontotemporal, Lewy body, vascular dementias) (ADRD), but can also be found
in the postmortem brains of older adults without ADRD. Thus, a central question in AD is why cognitive pathology
manifests in some individuals but not others. Animal models can provide insight into molecular mechanisms of
pathogenic protein aggregation and clearance, but generalizability to humans is less clear. This supplement will
build on the team’s previous collaborative research demonstrating that observational studies of cancer patients
can be used to gain insights into ADRD pathobiology. Specifically, the supplement will focus on the association
of accelerated cellular aging (i.e., DNA damage response, telomere shortening, cellular senescence, epigenetic
aging, inflammatory senescence-associated secretory phenotype, oxidative stress, cellular metabolism) and
plasma markers of neurodegeneration (e.g., amyloid-b, tau, ) with cognitive variability (i.e., an early indicator of
ADRD). We will leverage data from a newly-funded study (R01CA244328) of longitudinal change in PROs and
neurocognition in a novel cancer patient population, recipients of chimeric antigen receptor T-cell therapy (CAR-
T) for relapsed/refractory hematologic malignancies. Over 90% of CAR-T recipients experience excessive
release of pro-inflammatory cytokines (i.e., cytokine release syndrome or CRS) and/or neuroinflammation (i.e.,
immune effector cell neurotoxicity syndrome or ICANS) as side effects of treatment. We know of no other
disease paradigm by which such extreme phenotypes of accelerated cellular aging, inflammation, and
neuroinflammation can be observed in humans. As such, this supplement will provide a window into how these
phenotypes are associated with human cognitive processes in vivo. Parent grant data to be leveraged by
supplement includes smartphone-based real-time ecological momentary assessment (EMA) to asses cognitive
variability; validated PRO questionnaires; actigraphy data regarding sleep, physical activity, and sedentary
behavior; clinical information; and banked blood. New work in the supplement includes analysis of banked blood
at the same time points (i.e., pre-CAR-T baseline, 3 and 12 months later), the addition of a blood sample at 7
days post-CAR-T (i.e., when systemic inflammation and neuroinflammation are expected to be greatest), and
isolation and storage of T-cells at each time point to use as a resource for future scientific investigation. Goals
of the supplement are as follows: 1) to examine accelerated cellular aging, neurodegeneration, and cognitive
variability (i.e., an early indicator of ADRD) in the year after CAR-T therapy, 2) to determine psychosocial and
behavioral ADRD risk factors associated with accelerated cellular aging, neurodegeneration, and cognitive
variability in the year after CAR-T therapy, and 3) to explore the association of accelerated cellular aging with
recovery and response to CAR-T. Results will provide new insights into putative mechanisms of ADRD, which
will be evaluated further in ADRD patients in future studies.

Public health relevance
PROJECT NARRATIVE A central question in Alzheimer’s disease (AD) is why cognitive pathology manifests in some individuals but not others. In this supplement, we will leverage a newly-funded study (R01CA244328) of patients treated with chimeric antigen receptor T-cell therapy (CAR-T) to explore the roles of accelerated cellular aging and neurodegeneration on cognitive variability, an early indicator of AD. These patients may be at high risk of accelerated cellular and cognitive aging and neurodegeneration due to the high levels of systemic and neuroinflammation they experience after treatment.